Role of Insulin-like Signaling in Glial Responses to Axon Degeneration

DESCRIPTION (provided by applicant): Glial cells respond potently to neuronal damage, as well as neurodegenerative disease, by displaying overt changes in morphology, gene expression, migration, and phagocytic activity. Dysfunctional responses contribute to the progression of devastating neurological diseases, such as Alzheimer's disease and Parkinson's disease, and can also promote the onset of some autoimmune disorders. Despite the importance of glia in defending brain health, remarkably little is known about the molecular underpinnings of responses to neuronal damage. A vital long-term goal is to understand how basic glial immune reactions are triggered in the adult brain in response to damaged and dying neurons. The core cellular events (e.g. glial migration to injury sites and phagocytic clearance of neuronal debris) are highly conserved across species and recent work is revealing striking molecular conservation, as well. This proposal uses a well- established adult axotomy assay in Drosophila to investigate the molecular features of glial reactions; the fly offers a tractable genetic system to manipulate gene expression and function with exquisite cellular and temporal precision in vivo. Our preliminary work has identified a novel role for the evolutionarily conserved Insulin/insulin-like growth factor (IGF)-Like Signaling (ILS) pathway in orchestrating glial reactions to axon injury. Based on our findings, we hypothesize that ILS regulates glial immune responses in two fundamental ways: (1) Basal ILS activity in adult glia ensures that glia express key genes (i.e. the Draper receptor and adaptor Ced-6) required to detect and carry out responses to axon damage, and (2) Acute activation of the ILS pathway at injury sites triggers rapid responses in local glia to ensure that damaged neurons are cleared from the CNS. This proposal will employ powerful genetic-molecular tools to investigate how the ILS pathway contributes to axotomy-induced functions in glia. We will: (Aim 1) define the role of Insulin-like Receptor (InR) activity in each step of the glial response to axotomy, including altered gene expression, glial recruitment to injury sites, and glial phagocytic activity; (Aim 2) determine how insulin-like peptides (ilps), the InR ligands, influence basal expression of Draper and Ced-6, as well as each step of the injury response in local glia; and (Aim 3) define the molecular signaling cascades downstream of InR that are coupled to these important glial responses. This work will provide critical mechanistic insight into how damaged neurons communicate with glia to elicit responses and elucidate intrinsic molecular pathways that control these essential glial functions. Our findings will also offer a novel framework for exploring ILS components as therapeutic targets to treat CNS injury, as well as chronic neurodegenerative conditions.

Public health relevance
Glial cells, the primary immune responders in the brain, respond swiftly and powerfully to traumatic injury and to chronic neurodegenerative disease, and abnormal glial responses contribute to the progression of devastating neurological conditions, including multiple sclerosis, Alzheimer's disease, and amyotrophic lateral sclerosis. This proposal is relevant to public health because it will provide critically needed insight into te molecular and cellular signaling pathways by which damaged neurons elicit innate responses in glial cells. These discoveries will advance our understanding of neuron-glia communication in the brain, provide a springboard for the development of treatments to reduce the burden of neurological disorders and, thus, will be highly relevant to the NIH mission.